Role of Diabetes-Induced REDD1 in Heart Disease

Project Summary
Heart failure is a leading cause of mortality and morbidity in patients with diabetes and obesity, yet much remains
unknown regarding the molecular events whereby metabolic disease causes myocardial dysfunction. At the
cellular level, oxidative stress and inflammation are considered hallmarks of myocardial impairment. The
overarching hypothesis for this F31 fellowship proposal is that the stress response protein regulated in
development and DNA damage 1 (REDD1) plays a maladaptive role in the pathogenesis of heart disease by
augmenting the development of oxidative stress and inflammation in cardiomyocytes. Preliminary data support
that REDD1 expression is enhanced in the heart of mice fed a Western (i.e., high fat, high sucrose) diet and in
cardiomyocyte cultures exposed to the saturated fatty acid palmitate. Recent studies from our laboratory
demonstrate a key role for REDD1 in the development of diabetes-induced oxidative stress. More specifically,
REDD1 acts via a GSK-3β-dependent signaling axis to suppress the nuclear factor erythroid-2-related factor 2
(Nrf2) antioxidant response in the retina of diabetic mice. Additionally, REDD1 was found to promote
inflammatory signaling in macrophages by direct sequestration of inhibitor of κB (IκB), leading to nuclear factor
kappa B (NF-κB) activation. A role for REDD1 in activation of these two non-conventional signaling axes for Nrf2
repression and NF-κB activation has never been interrogated in the heart. Nor is it know if REDD1 contributes
to the development of cardiac dysfunction. To test the hypothesis, I will pursue an experimental protocol involving
model systems ranging from intact mice to cardiomyocyte cell cultures. Aim 1 will investigate the mechanism
whereby consumption of a Western diet promotes transcriptional upregulation of REDD1 in the heart. Aim 2 will
investigate the role of REDD1 in the development of oxidative stress and inflammation in cardiomyocytes. Aim
3 will determine the impact of REDD1 deletion on the development of cardiac dysfunction. In addition to my
continued graduate training in molecular biology and cellular physiology at Penn State College of Medicine, this
fellowship will provide key training opportunities with experts in cardiovascular dysfunction. Specifically, I will
learn to properly culture and manipulate adult ventricular cardiomyocytes and develop the technical expertise in
echocardiography to assess the impact of REDD1 on cardiac function in transgenic mice. With respect to
outcomes, the project will not only expand my skills and systems of analysis beyond those of my primary
Sponsor, but will also potentially identify and characterize a unifying regulatory mechanism whereby metabolic
disease limits the endogenous antioxidant response and upregulates inflammation in heart. Identification of such
a mechanism is significant because it will validate new targets for the development of preventative and/or
therapeutic interventions aimed at addressing the molecular basis of heart failure.

Public health relevance
Project Narrative A deficit in our understanding of the molecular defects that underlie the development of heart disease represents a critical barrier to the design and implementation of therapeutics that more fully address its molecular pathogenesis. The present application will identify a novel mechanism that potentially regulates the endogenous antioxidant and inflammatory responses of the heart in diabetes. These findings are expected to provide new targets for intervention and lead to the development of innovative therapies for a leading cause of mortality and morbidity.